Developmental Funds

DEVELOPMENTAL FUNDS – PROJECT SUMMARY/ABSTRACT
Developmental Funds (DF) at the Montefiore Einstein Comprehensive Cancer Center (MECCC) are used to invest in new scientific initiatives to catalyze multidisciplinary research, interdisciplinary team science and research relevant to the MECCC Catchment Area (CA). Funds are aligned to the 10 strategic scientific priorities as detailed in the MECCC Strategic Plan 2021-2026: (1) to be a national model for community outreach and engagement and research focused on CA; (2) cancer therapeutics/drug development with specific focus on small molecules and targeted agents; (3) cancer immunology and new immunotherapies/cell therapies; (4) cancer biology and signaling; (5) cancer dormancy, tumor microenvironment and metastasis; (6) cancer and aging; (7) cancer epidemiology focused on the Bronx CA patient population; (8) tumor genomics and precision medicine; (9) environmental and behavioral factors affecting common cancers in the Bronx CA; and (10) health services and health implementation science. Four distinct Pilot Project Programs were developed during the current project period: (1) MECCC Team Science Awards; (2) MECCC Translational Research and Investigator-Initiated Clinical Trials Pilot Program; (3) MECCC Catchment Area Research Pilot Program; (4) MECCC Research Program Pilot Projects. Use of DF is based upon a rigorous assessment of MECCC strategic needs, as articulated in the Center’s strategic planning process and coordinated by the MECCC’s Senior Leadership Team. A substantial proportion of DF was allocated to support 9 pilot projects focused on research relevant to the CA. MECCC Administration has refined processes for the solicitation and review of pilot project applications and the allocation of funds. Strategic scientific priorities funded with DF, relevant to the CA and that directly impact our Bronx patients, include chemoprevention of colon cancer, onco-fertility and strategies to increase access to services, environmental exposures from air pollution and links to lung cancer, and understanding challenges to effective diagnosis and treatment of liver cancer for effective intervention. Future plans for the expenditure of DF in the next project period will continue to reflect priorities designated in the MECCC Strategic Plan. The goal of this funding mechanism is to facilitate research that will generate pilot data for future competitive NCI grant applications.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward DEVELOPMENTAL FUNDS - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page